Device Automation of an FDA-cleared CD-Microfluidic Platform for Rapid Tissue Microsizing

ABSTRACT
There is a need in the market for a true platform technology that automates the tissue processing
experience. Syntr Health Technologies has dedicated the last nine years to developing the
technology that can streamline tissue processing. Our FDA-cleared SyntrFuge System and
SyntrFPU360, is a platform technology that can process a variety of different tissue types such as
cancer tumors of kidney, liver, brain, and breast tissue by dissociating them into single cells to
better understand tumor tissue heterogeneity, of which the single cell analysis market is valued at
$3.3 Billion and expected to grow to $6.3 Billion by 2026.
Additionally, our platform can be used to microsize autologous adipose tissue to be used for
reinjection back into the patient to treat medical conditions of the aging population such as diabetic
foot ulcers, knee osteoarthritis, and breast cancer reconstruction surgery. Syntr Health successfully
completed an SBIR Phase I grant where we utilized microsized adipose tissue to heal diabetic
ulcers in an animal model. This study had an important role in developing a treatment modality
that translated successfully into humans. Preliminary human clinical data shows significant
diabetic foot ulcer wound closure within 28 ± 4 days using autologous adipose tissue processed in
our platform. The diabetic foot ulcer market is currently valued at $1.98 Billion with a CAGR of
8.2%. This high growth potential is attributed to the increase of the diabetic population. Moreover,
the use of microsized adipose tissue is showing great promise in intra-articular injections to knee
joints for the treatment of osteoarthritis (OA). The knee OA market in North America is currently
valued at $5.9 Billion and growing at a CAGR of 8.8%. Over 88% of individuals with OA are 45
or older. The high growth potential of this market is largely attributed to the increase of the aging
population along with the increase in obesity rates.
Our platform technology for the rapid processing and/or microsizing of tissues can disrupt these
markets in a major way. The full automation and market readiness of this technology in this Phase
II SBIR is paramount to increase favorability in the adoption of this much needed technology in
various medical fields..

Public health relevance
PROJECT NARRATIVE Automation of medical technology is key for usability in a clinical setting to help reduce user interaction, provide repeatability and reproducibility, and maintain cleanliness. This project will finalize the automation of an FDA-registered system for microsizing autologous adipose tissue for the use in regenerative medicine. This project will provide a valuable role in developing a fully automated system for the use in multiple medical procedures in the regenerative medicine field.